ARTHRITIS: SHIGELLA FLEXNERI ENTERITIS JUVENILE LOWLAND GORILLAS

Two juvenile lowland gorillas (Gorilla gorilla gorilla) experienced polyarthropathies subsequent to Shigella flexneri enteritis. The clinical sign of lameness and soft tissue swelling resolved with anti-inflammatory and antibiotic therapy. One of the animals had a major histocompatibility class I allele with some sequence similarity to HLA-B27. This allele is associated with postinfection reactive arthritis in humans. Key Words Gorilla, arthritis, arthropathy, Shigella, reactive arthritis